International Bioethics Research Postdoctoral Training - C. Asia Network

Project Summary/Abstract
This D43 International Bioethics Research Post-Doctoral Training (IBRT) – C. Asia Network will
selectively recruit three post-doctoral (M.D., Ph.D. or M.D. / Ph.D.) inter-disciplinary trainees per year over a 5-
year period (n=15 total) from four leading national medical universities affiliated with respective Ministries of
Health in Central Asia LMICs including: Azerbaijan Medical University, Baku, Azerbaijan; Kazakh National
Medical University, Kazakhstan; Kyrgyz State Medical Academy, Bishkek, Kyrgyz Republic; and Tashkent
Pediatric Medical Institute, Uzbekistan. The program will serve as a comprehensive model for understanding
bioethics, and learn about quantitative and qualitative research methodology and analytic techniques
appropriate for the study of bioethics research topics relevant in the corresponding C. Asia LMICs
(Foundations Phase). The trainees will implement mentored in-country bioethics research project relevant to
the LMIC health needs and priorities (Implementation). They will receive expert guidance aligned with their
area of research interest and scholarship (Research Project). There will be provision of project funding with
appropriate budget justification. The participating program mentor group will include US, High Income Country,
Turkey and LMIC expert faculties. The program will foster interdisciplinary collaborations in cross-cutting
priority areas in the region and contribute to the development of LMIC leadership in bioethics research across
the C. Asia Network (Sustenance). Finally the trainees will assume expanded roles to provide leadership in
research ethics review committees, contribute to the application of responsible conduct of research, and
provide expert bioethical consultations in their respective LMIC institutions (In-Country Impact). The
overarching goal is to contribute to the development of an independent group of critical thinkers and leaders in
bioethics research in the C. Asia region. The trainees will have opportunities to interact with leaders in
bioethics and global health research and to present their work. They will also participate in recurring annual
LMIC Bioethics Symposia and annual Research Methodology and Ethics Summer Institutes. The program will
provide bursaries for trainees as well as faculty during the grant’s tenure to participate in these networking
events (Networking). The PD/PI has two decades of experience in directing D43 programs and R25 training
and research education program at Boston Children’s Hospital in collaboration with the Harvard T.H. Chan
School of Public Health including a highly successful R25 International Research Ethics Initiative in Turkey/C.
Asia.

Public health relevance
Project Narrative This 5-year D43 International Bioethics Research Post-Doctoral Training (IBRT) – C. Asia Network will provide advanced bioethics and research training for 3 post-doctoral trainees per year (n=15) from four leading national medical universities affiliated with respective Ministries of Health in Central Asia Low and Middle Income Countries (LMICs): Azerbaijan Medical University, Baku, Azerbaijan; Kazakh National Medical University, Kazakhstan; Kyrgyz State Medical Academy, Bishkek, Kyrgyz Republic; and Tashkent Pediatric Medical Institute, Uzbekistan. Following the Foundations Phase engaged in intensive coursework in bioethics and research methods, didactics, and research project mentoring at Boston Children’s Hospital Harvard Medical School and Harvard T.H. Chan School of Public Health, the trainees will return to the their countries to conduct mentored in-country bioethics research (Implementation Phase). The goal of the program is to assemble an independent group of critical future leaders in bioethics research in the C. Asia region (Sustenance and In-Country Impact Phases).